Endothelial protocadherins in vascular development and disease

PROJECT SUMMARY
Transcription factors Klf2 and 4 are strongly induced in vascular endothelial cells (ECs) by fluid
shear stress from blood flow, where they confer vascular stability and suppress the inflammatory
pathways and genes responsible for atherosclerosis and other diseases that involve vascular
inflammation. This application is based on our recent discovery that gamma protocadherins
(Pcdhg) block Notch-dependent transcription and thus suppress expression Klf2/4 in ECs, which
facilitates vascular inflammation and disease. Pcdhg knockout in endothelial cells limits
atherosclerosis in mice and alters vascular morphogenesis in the postnatal retina. Based on our
findings, we hypothesize that Pcdhg is a key regulator of vascular stability and resilience that
contributes to vascular morphogenesis but whose inhibition provides a novel means of treating
vascular inflammation without compromising host defense against pathogens. To test these
hypotheses, we propose to: 1) Determine the effects in mice of knocking out the Pcdhg cluster
in ECs or inhibiting the key isoform Pcdhga9, examining multiple models of vascular
inflammation. 2) Elucidate the mechanism by which Pcdhg controls Klf2/4 expression, focusing
on interactions with the Notch pathway. 3) Characterize the effects of EC Pcdhg knockout on
angiogenesis and arteriogenesis in the postnatal retina and determine the molecular
mechanisms of observed effects.

Public health relevance
PROJECT NARRATIVE Based on our recent discovery that gamma protocadherins expressed in vascular endothelial cells suppress Notch-dependent transcription and hence the critical anti-inflammatory transcription factors Klf2 and 4, we will investigate their roles in multiple models of vascular inflammatory disease in mice, elucidate molecular mechanisms by which gamma protocadherins regulate Klf2/4, and investigate the roles of gamma protocadherins in normal vascular development and patterning.